Therapeutic value and mechanistic action of PSPC1 in AML

Summary
Acute myeloid leukemia (AML) is a biologically and genetically heterogeneous hematopoietic malignancy
characterized by the blockage of myeloid cell differentiation and uncontrolled proliferation of immature myeloid
cells. Although treatment options for AML have progressed over the past few decades, the 5-year overall survival
of AML patients is still <30%. Therefore, there remains a high unmet need to develop novel and more effective
AML therapies, which requires a
deeper understanding of the pathophysiology of AML and the identification of
novel and effective molecular targets. Our preliminary data showed that paraspeckle protein component 1
(PSPC1) is highly overexpressed in virtually all types of human AMLs, and PSPC1 knockdown (KD) profoundly
suppresses proliferation, promotes apoptosis, and induces robust differentiation of diverse AML cells and
abrogates their leukemogenic capacity. Furthermore, Pspc1 deletion has little effect on hematopoietic
stem/progenitor cell (HSPC) function, steady-state hematopoiesis, or normal mouse development. Despite being
a member of the Drosophila Behavior/Human Splicing (DBHS) protein family associated with nuclear
paraspeckles containing SFPQ and NONO, neither paraspeckles nor NONO is involved in PSPC1-mediated
hyperproliferation and myeloid differentiation arrest in AML cells. Moreover, neither the N-terminal RNA
recognition/binding motifs nor the C-terminal coiled-coil domain (essential for dimerization) of PSPC1 is
important for the pathogenic function of PSPC1 in AML cells. Integrated PSPC1 ChIP-seq and RNA-seq
analyses in WT vs. PSPC1 KD AML cells identified key target genes important for oncogenesis, proliferation,
survival, and differentiation of AML cells, and motif analysis revealed putative transcription factors (TFs) that
may associate with PSPC1 in target gene transcriptional activation and repression. Based on these exciting
findings, we hypothesize that PSPC1 acts as a novel determinant for AML leukemogenesis and that PSPC1
inhibition represents a safe and highly effective therapeutic strategy for various AMLs where PSPC1 interacts
with key TFs to dictate a unique leukemic transcription program underlying multiple AMLs. To test this
hypothesis, we will: 1) use the loss-of-function genetic strategy to further validate that PSPC1 is a novel
therapeutic target for AML; 2) determine whether PSPC1 is a common target for AML induced by different AML
drivers and whether other oncogenes are required for PSPC1 to induce AML; and 3) dissect the molecular
mechanisms by which PSPC1 induces AML by defining PSPC1-regulated common transcriptome and the
PSPC1 interactome across multiple AML subentities and studying the contribution of PSPC1 partners/target
genes to AML characteristics and leukemogenesis. The success of the proposed studies will gain fundamental
knowledge on AML biology and leukemogenesis by establishing PSPC1 as a critical and novel determinant for
AML leukemogenesis, which can lead to the breakthrough in AML treatment by developing ways to target PSPC1
using RNAi and/or small molecule inhibitors as a safe and effective therapeutic strategy for various AMLs.

Public health relevance
Narrative This application investigates whether PSPC1 inhibition represents a safe and highly effective therapeutic strategy for AML in which PSPC1 interacts with key transcription factors to dictate a unique leukemic transcription program underlying various subentities of AML. The proposed studies could establish PSPC1 as a critical and novel determinant of AML leukemogenesis, which can lead to a breakthrough in AML treatment.